Parkinson's disease therapies targeting GUCY2C

PROJECT SUMMARY/ABSTRACT
Parkinson’s disease is the second most common cause of age-related neurodegeneration in the U.S. In
Parkinson’s disease, mitochondrial dysfunction in midbrain dopaminergic neurons in the substantia nigra induces
oxidative stress and cell death. In turn, this neurodegeneration leads to dopamine depletion, which underlies the
motor dysfunction and dementia that are hallmarks of this disease. Current therapies raise dopamine levels to
relieve motor symptoms, but do not prevent neurodegeneration, disease progression, or death. Thus, there is
an essential unmet need to develop novel therapeutic strategies that protect dopaminergic neurons from
degeneration to prevent and treat Parkinson’s disease. Guanylyl cyclase C (GUCY2C) is the intestinal receptor
for the hormone uroguanylin produced in intestine, with a canonical role in fluid and electrolyte balance. In
intestine, this paracrine axis supports mitochondrial structure and function, and its disruption, universally
reflecting hormone loss, is central to the pathophysiology of cancer; inflammation and autoimmunity; and toxic
injury. Recently, uroguanylin emerged as the afferent limb of endocrine axes controlling two discrete circuits in
brain. GUCY2C in neurons in the hypothalamic ventral premamillary nucleus controls leptin signaling regulating
satiety and body weight. Disrupting this gut-brain endocrine axis contributes to hyperphagia underlying obesity.
Further, GUCY2C is expressed by dopaminergic neurons in the substantia nigra, although its
(patho)physiological function remains undefined. Our preliminary studies reveal that silencing GUCY2C
increases the vulnerability of dopaminergic neurons in the substantia nigra in mice to degeneration induced by
MPTP, a mitochondrial toxin that selectively kills dopaminergic neurons in the substantia nigra in rodents,
primates, and humans. Moreover, GUCY2C signaling supports the mitochondrial transcriptome central to
preventing Parkinson’s disease, and silencing GUCY2C causes a significant loss of mitochondrial protein within
the substantia nigra. These preliminary studies suggest a model in which the GUCY2C-uroguanylin gut-brain
endocrine axis controls midbrain vulnerability to toxic insults by maintaining mitochondrial integrity to protect
dopaminergic neurons in the substantia nigra. Thus, studies here explore the novel Physiological Hypothesis
that uroguanylin secreted by intestine and GUCY2C expressed in the midbrain form a novel endocrine gut-brain
axis that protects dopaminergic neurons, opposing toxic degeneration. The Mechanistic Hypothesis suggests
that GUCY2C protects the integrity of midbrain dopaminergic neurons by supporting mitochondrial structure and
function. The Therapeutic Hypothesis suggests that exogenous GUCY2C ligands protect midbrain
dopaminergic neurons from toxic insults, potentially opposing the development and progression of Parkinson’s
disease. The possibility of translating these studies into new therapeutic strategies to prevent and treat
Parkinson’s disease can be appreciated by considering that the GUCY2C ligands linaclotide (Linzess™) and
plecanatide (Trulance™) are FDA-approved to treat chronic constipation syndromes.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease, the second most common cause of age-related neurodegeneration in the U.S., in part reflects abnormal mitochondrial function in midbrain neurons, which produces cell death. Current therapies relieve the hallmark symptoms of abnormal movements, but they do not prevent neurodegeneration, disease progression, dementia, or death. This proposal will explore the novel hypotheses that there is a previously unrecognized link between hormones secreted by the intestine and midbrain neurons that protects their mitochondria against toxic injury, and that those hormones can be used as drugs to prevent and treat Parkinson’s disease.